Enhancing Research Capacity for Tribal Colleges and Rural Native American Populations Through an Indigenized Approach

ABSTRACT: GLNARCH XI Capacity Building
The unique strength of the proposed GLNARCH Capacity Building Core is the adoption of the
model developed by the Native Environmental Health Research (NEHR) network previously
funded under NARCH VIII. The NEHR model nurtures collaborations between Tribes, Tribal
Colleges and Universities (TCUs), and Native-serving mainstream institutions. Through this
network, participants can work collaboratively by sharing, and directing the necessary resources
to address pressing tribal health concerns. In this way, the GLNARCH Capacity activities (both
proposed here and ongoing) augment and leverage valuable, scarce resources in the most
underfunded Indian Health Service (Bemidji) region, while also offering additional opportunities,
such as professional development and consultation, to all participants. The activities in this
Capacity Component will be executed by an experienced, established team with institutional
support from the Medical College of Wisconsin (MCW), University of Wisconsin System (UW),
and Great Lakes Inter-Tribal Council (GLITC), with additional support from the Inter-Tribal
Council of Michigan (ITCMI). This proposal supports and complements our other GLNARCH
efforts via independently achievable aims with their own distinct valuable impacts. This
proposed Capacity Project will develop research capacity at each center (TCU and/or tribal
community) as well as coordinate these into a regional network (NEHR). Doing so builds on
established relationships under the previous funding cycle.

Public health relevance
PROJECT NARRATIVE: GLNARCH XI Capacity Building This proposed Capacity Project will develop research capacity at each center (TCU and/or tribal community) as well as coordinate these into a regional network (NEHR). This will fill crucial needs in rural, underfunded AI/AN communities and institutions.